Center for Aging in Diverse Communities: Ending Health Inequities in Older Adults

PROJECT SUMMARY/ABSTRACT
The University of California San Francisco (UCSF) Center for Aging in Diverse Communities (CADC), an NIA-
funded RCMAR since 1997, conducts research, training, and mentoring in minority aging and health disparities
research. CADC offers a rich, multidisciplinary environment with social, behavioral, epidemiological, cognitive
neuroscience, statistical, and internal medicine faculty providing mentoring and training support. The San
Francisco Bay Area provides access to a wide range of diverse racial/ethnic, socioeconomic, and sexual and
gender minority older adult populations. Our on-going studies with diverse rural and urban communities and
solid relationships with over 100 community and clinical partners serving older adult disparity populations
provide applied laboratories for mentoring. Our research theme addresses two NIA priorities: (1)
understanding mechanisms of health disparities and developing effective interventions to reduce them; and (2)
to develop infrastructure for high quality research. Since 1997, CADC has mentored over 90 minority
underrepresented early investigators who have made significant contributions to minority aging research. In the
past 5-year funding cycle, we mentored 25 minority early investigators and funded 26 pilot projects. Our cores
will continue within the new RCMAR organizational framework. The Administrative Core (AC) will coordinate
integration of the cores, selection of CADC Scientists, reporting, and external advisors. The Research &
Education Component (REC) will provide continual mentorship and pilot study funding for CADC Scientists.
The Analysis Core (AnC) will advance and disseminate methodological resources and measures for minority
aging and health disparities research. The Community Liaison & Recruitment Core (CLRC) will enhance
recruitment and retention and promote engagement of diverse communities in research. Our CADC cores
contribute jointly and uniquely to mentoring and training CADC Scientists and others in conducting research to
resolve the challenging issues facing our older adult disparity populations. CADC's aims are to: (1) select 3-4
CADC Scientists (underrepresented junior investigators) per year, provide them with pilot study funding, and
mentor them to develop independent research careers in health disparities and minority aging research; (2)
develop and disseminate (a) methods for conducting interventions to ameliorate disparities among older adults,
(b) methods for developing/selecting measures appropriate for disparity populations, and (c) methodological
resources on advanced research and statistical methods; and (3) advance the science of community
engagement and recruitment to increase participation of disparity populations in research, and mentor CADC
Scientists on these methods. CADC will contribute to diversifying the workforce by promoting the expertise
and careers of exceptionally talented underrepresented CADC Scientists to develop independent research
careers. The cumulative experience, commitment to health equity, and professional networks of CADC Faculty
and Scientists in the research and local communities ensures that we will achieve these aims.

Public health relevance
NARRATIVE For 20 years, the UCSF Center for Aging in Diverse Communities (CADC) has been dedicated to eliminating health disparities in minority aging populations. Our research focuses on understanding health disparities and building and testing community-engaged interventions to reduce disparities among older adults. Our most important mission is to train and mentor talented, underrepresented junior investigators to develop independent research careers focused on health disparities and aging issues. Our mentoring is informed and optimized by our research, community partnerships, diverse local populations, and decades of mentoring experience.